Developmental Core

DEVELOPMENTAL CORE: ABSTRACT
The Developmental Core of the UPSTREAM Research Center will foster innovative and collaborative
research related to the impact of cancer prevention and control in communities with persistent poverty. The
Core will play a key role in advancing the mission of the Center by stimulating novel research directions toward
the upstream fundamental causes of cancer, facilitating transdisciplinary collaboration across Center activities.
The Developmental Core will capitalize on the breadth and depth of research expertise at the intersection of
poverty and cancer at the three Comprehensive Cancer Centers in Northern California: Stanford, the University
of California at San Francisco (UCSF), and the University of California at Davis (UCD). Funded projects will
synergize with, and extend the research performed under Projects 1 and 2, and the Research and Methods
Core. We propose to fund pilot projects in three complementary research tracks: 1) Supporting
community prioritized interventions and projects related to income support and cancer equity, 2) Elucidating
mechanisms linking lack of income to drivers of cancer inequities, and 3) Facilitating collaborative
transdisciplinary projects between early career scholars, clinicians, and community partners. Funds will be
used by investigators and community partners to develop pilot data that will serve as the basis for obtaining
subsequent research funding through external peer-reviewed grants. We will work collaboratively with our
community partners, the Persistent Poverty Initiative Network, and the Network Steering Committee. Aim 1 of
the Core is to administer and support 3 pilot projects per year to catalyze innovative and collaborative research
related to the impact of GBI and EITC programs on cancer prevention and control in our selected communities
with persistent poverty. Aim 2 of the Core is to build capacity for sustainable bi-directional partnerships
between university and community partners to reduce cancer inequalities in persistent poverty areas through
community-driven research. The sustainable products of the Developmental Core activities will be the creation
of novel avenues for collaborative research on the social determinants of cancer in persistent poverty
communities, broad transdisciplinary participation in Center activities, and the career development of pilot
project awardees committed to a focus on research in persistent poverty areas of Northern California.